Digital clinical hypnosis for chronic pain management

Project Summary
Chronic pain is a prevalent, disabling problem affecting as many as 116 million adults in the United States.
However, there are very few treatment options for chronic pain management, and those that are available are
inadequate for the majority of those with this condition. Many also have significant negative side effects or are
associated with significant adverse events. A growing body of research supports the short- and long-term
benefits of hypnosis treatment for chronic pain. Hypnosis treatment has also been shown to have few negative
side effects, while also having additional benefits over and above reductions in pain intensity, including
reductions in anxiety and improvements in sleep quality. However, access to hypnosis treatment is limited
because few health care providers are trained in its use. HypnoScientific, Inc. was established to increase
access to effective hypnosis treatment by developing and making it available online and via mobile devices,
i.e., digital hypnosis. To maximize efficacy, HypnoScientific’s products are informed by the findings from a well-
established and ongoing research program studying the mechanisms of hypnotic analgesia, including pilot
research that has tested a hypnosis digital therapeutic prototype. The first aim of the currently proposed Phase
I project is to develop the hypnosis digital therapeutic prototype further by: (1) updating and increasing the
number of hypnosis media tracks offered, (2) designing a ruleset for content delivery, (3) developing UI/UX
standards to optimize ease of use and efficacy, and (4) developing a content management system consistent
with this ruleset, that would allow content to be provided to individuals with chronic pain via an existing
telehealth company’s platform. The project’s second aim is to evaluate the feasibility of the technology delivery
system developed in Aim 1 in a sample of 50 individuals with chronic pain. These individuals will be
randomized to having more access (i.e., 8 full weeks) or less access (i.e., 4 weeks of no access followed by 4
weeks of access) to the therapeutic, and feasibility variables will be collected during and after the trial. The
findings from this trial will allow us to determine if the proposed approach for making hypnosis treatment more
accessible to the millions of individuals who could benefit from it is viable. The findings will also provide data
that will inform the design of a definitive trial testing the technology in a Phase II project.

Public health relevance
Project Narrative Chronic pain remains a significant health problem for over 100 million people in the USA, and the chronic pain treatments that are available are not adequately effective, are associated with significant adverse events, or both. Hypnosis treatment is a viable nonpharmacological approach for chronic pain management. This project aims to take the first steps towards commercializing a treatment approach – digital hypnosis – that could make effective hypnosis treatment for chronic pain more accessible to the millions of individuals who could benefit from this approach.